Discrete Polymer-based, Metal-free MRI Contrast Agents

Project Summary
Structural dispersity in synthetic polymers is paramount for their clinical use and regulatory approval. In this
project, we propose the development of water-soluble discrete bottlebrush polymers bearing alternating
phospholipid and fluorinated comonomers to enable their clinical applications as metal-free19F MRI contrast
agents. The novelty of the proposed polymer system is that it combines: 1. discrete molecular weight (as
opposed to conventional disperse polymers); 2. multifunctionality of branched architectures; 3. high water
solubility and biocompatibility of phosphorylcholine groups; and 4. exogenous and chemically identical signal
of19F groups. Rational design of the brush polymer architecture, comonomer sequence, and
lipophilic-hydrophilic balance is anticipated to suppress signal broadening and yield discrete synthetic
polymer-based platforms that can be further extended to other targeted imaging and sensing strategies.

Public health relevance
Project Narrative The repeated administration of Gd(III)-based MRI contrast agents raises significant concerns due to the potential for in vivo deposition, hypersensitivity, and lethal systemic fibrosis. We propose to develop discrete (Đ = 1.0) brush polymer-based 19F-MRI contrast agents to overcome the longstanding challenges of dispersity, size, rapid renal clearance, and low signal-to-noise ratio of synthetic contrast agents. If the proposed study is successful, it will provide metal-free MRI contrast agents that are safer, selective, more reliable, and chemically versatile for the diagnosis and monitoring of damaged blood vessels, small tumors, and abnormal tissues.